An integrated approach to understand and diagnose congenital Chagas disease

PROJECT SUMMARY/ABSTRACT
Nearly 6 million people worldwide are infected with the parasite Trypanosoma cruzi, the agent of Chagas
disease, and vertical transmission accounts for 22% of all new infections. Between 5-10% of T. cruzi-infected
women will transmit the infection to their children, leading to a spectrum of disease in the infant: the majority of
infected infants are asymptomatic but up to 40% have systemic disease involving the heart, brain, or liver.
Congenital infection can also result in premature birth, or, in rare cases, neonatal death. Nearly a third of
infants, even those with no symptoms, will develop chronic cardiac and gastrointestinal problems later in life.
Unfortunately, up to 75% of affected infants do not receive timely diagnosis or treatment. Most T. cruzi
infections occur in resource-limited rural areas of Latin America where advanced diagnostic tools are
unavailable. Because treatment is safer and more effective during infancy than in older children and adults,
early diagnosis is critical. Infected infants will continue to miss their opportunity for lifesaving treatment until we
develop better algorithms to identify high-risk infants and accurately diagnose congenital Chagas disease in
the perinatal period. Our long-term goal is to accelerate the elimination of congenital Chagas disease by
developing tools to predict and diagnose T. cruzi infections in infants. In this project, we propose to (1) identify
maternal clinical and epidemiological risk factors for vertical transmission; (2) investigate the parasite’s
mechanisms of invading through the placenta using parasite genotyping and identifying gene expression
signatures associated with transmission; and (3) optimize and validate a new test for congenital T. cruzi
infection using recombinase polymerase amplification (RPA), a DNA detection method that can be performed
without advanced laboratory equipment or expertise and is adaptable to point-of-care platforms. To accomplish
these goals, we propose a cohort study of pregnant women and their infants in Santa Cruz, Bolivia, a highly
endemic area for T. cruzi. We hypothesize that by combining traditional epidemiological analyses with cutting-
edge genomic techniques, we can better predict which infants born to women infected with T. cruzi are at
highest risk of congenital infection. We also hypothesize that a new RPA assay will allow us to diagnose these
infants more frequently and earlier than current standard diagnostics, which perform poorly to detect congenital
infection in neonates. In Aim 1, we will identify risk factors for vertical transmission in a cohort of T. cruzi-
infected women to better identify high-risk infants. In Aim 2, we will characterize parasite genetic factors
associated with vertical transmission of T. cruzi using genotyping and transcriptomics. Finally, in Aim 3, we will
optimize our RPA assay and test it in the clinical setting to evaluate its ability to diagnose neonates with
congenital Chagas disease. Our innovative approach will integrate field epidemiology, cutting-edge sequencing
techniques, and new diagnostics to identify infected infants in the first weeks of life. These advances have the
potential to lead to a paradigm shift to accelerate cure of Chagas disease’s youngest victims.

Public health relevance
PROJECT NARRATIVE The parasite that causes Chagas disease infects almost six million people globally and causes more morbidity than any other parasitic pathogen in the Americas; congenital infections account for 22% of the 39,000 new infections annually, but unfortunately, many diagnoses are missed because of complicated diagnostic algorithms and a lack of tools to predict which infants are at highest risk. We propose a cohort study in Santa Cruz, Bolivia, where 20% of young women have Chagas disease, to identify risk factors for mother-to-child transmission, understand parasite gene expression signatures that increase risk of infection, and develop better diagnostic tests to detect infections soon after birth. Our innovative approach will integrate field epidemiology, cutting-edge sequencing techniques, and new diagnostics to improve our ability to identify pregnancies at high risk for vertical transmission and diagnose infected infants in the first weeks of life, thus increasing the number of affected children who are cured and decreasing the burden of Chagas disease worldwide.